CSHL 2024 Gene Expression & Signaling in the Immune System Conference

Cold Spring Harbor Laboratory Conference
GENE EXPRESSION AND SIGNALING IN THE IMMUNE SYSTEM
April 16-20, 2024
ABSTRACT
The proposed meeting on Gene Expression and Signaling in the Immune System, to be held in spring
2024, will focus on the most recent advances in this rapidly moving field. The meeting will be open, with
attendance limited only by the facilities available to a maximum of ~425 participants. Oral presentations will
be delivered by a combination of invited speakers and those selected from submitted abstracts. This ensures
the participation of junior and senior leaders in the field and the presentation of the most exciting results
emerging at the time of the meeting. A particular emphasis will be made to ensure that a substantial number
of speakers will be advanced trainees or junior PIs. The oral presentations will be complemented by poster
presentations in two sessions, also selected from submitted abstracts. The areas to be covered in the 2024
meeting include 1) Regulation of gene expression; 2) Differentiation; 3) Signaling at the membrane; 4)
Intracellular signaling; 5) Intercellular communication; 6) Host:microbe interactions; 7) Immune Responses;
and 8) Tissue-immune communications (immunophysiology). Rather than focusing on one particular type of
immune cell or disease process, the meeting will highlight mechanistic approaches that aim to rigorously
advance our knowledge of how the processes of signal transduction and gene regulation operate within the
immune system at different scales. Ample opportunity is provided for the presentation of important, late-
breaking findings. The meeting format also ensures and encourages highly productive discussions, particularly
during meals and in poster sessions. The meeting will foster interactions among immunologists working in
related areas, and provide a forum for the development of new ideas and approaches for current and future
investigations of regulation of signaling and gene expression in the immune system.

Public health relevance
Cold Spring Harbor Laboratory Conference GENE EXPRESSION AND SIGNALING IN THE IMMUNE SYSTEM April 16-20, 2024 PROJECT NARRATIVE The immune system provides the body’s major defense against both infectious diseases and cancer. It employs a wide variety of strategies to recognize and remove microbes and distressed cells, as well as providing the protective immunity against future infections that forms the basis of vaccination. The immune system may also respond aberrantly or too aggressively, as in various forms of allergy, or may attack the body’s own cells, as in autoimmune diseases. The cells of the immune system have to interpret a wide variety of signals to respond in an appropriate manner to a given challenge. How these signals are received, transmitted, and interpreted forms the scope of this important conference series. The series is notable because it attracts a unique group of immunologists focused on genes and their mechanisms of action whose research is at the cutting edge in defining how the immune system functions.